microRNA Regulation of Gamma-herpesvirus Latency and Reactivation

PROJECT SUMMARY
Epstein-Barr virus (EBV) persistently infects >90% of adults worldwide. In individuals with congenital or acquired
immune deficiencies, such as patients undergoing organ transplant or living with HIV/AIDS, life-long persistent
infection can lead to a variety of cancers. Like all herpesviruses, EBV has both a latent and a lytic replication
phase; the ability to switch between these programs is key to long-term viral persistence. Periodically, latent
EBV reactivates to produce infectious virus, which is thought to increase the pool of infected cells and sustain
persistent infection. Molecular mechanisms regulating latency and the switch to lytic replication are not entirely
understood. MicroRNAs (miRNAs) are small, non-coding regulatory RNAs that govern many biological
processes including cell state transitions and the development of immune responses. EBV encodes
evolutionarily conserved viral miRNAs that are active during stages of the viral life cycle when viral proteins are
highly restricted and that can interfere with host signaling pathways and anti-viral defense mechanisms on
multiple levels, leading us postulate that viral miRNAs represent an important part of why host immune responses
fail to clear persistent infection. Despite significant efforts advancing our understanding of EBV miRNA functions,
little is known about their contributions to infection in vivo. Based on preliminary findings, we hypothesize that
EBV miRNAs act as virulence factors and coordinate aspects of latency and reactivation that facilitate virus
persistence within a host. In this project, we will examine regulatory non-coding RNA interactions, asking
specifically how viral and cellular miRNAs cooperatively shape dynamic cell states during EBV infection, and
determine the miRNAs influencing critical decisions that impact virus reactivation. We aim to elucidate the critical
miRNAs and miRNA-mediated mechanisms (targets and pathways) regulating the EBV latent to lytic switch. To
test our hypothesis that viral miRNAs facilitate persistence in vivo, we will leverage the rhesus lymphocryptovirus
model to examine viral miRNA phenotypes in a natural primate host. Studies proposed herein have utility in
developing RNA-based therapeutic strategies against viral disease and important implications for advancing g-
herpesvirus vaccine development.

Public health relevance
PROJECT NARRATIVE Key to the success of life-long herpesvirus persistence is the ability to switch between latent and lytic replication modes. This project addresses important microRNA-mediated mechanisms that influence critical decisions impacting virus-host relationships. Proposed studies identify miRNAs that are essential controllers of virus reactivation, examine the molecular mechanisms governing the latent to lytic switch, and, importantly, elucidate the role of virus-encoded miRNAs in facilitating virus dissemination and persistence in vivo. These studies have direct utility in developing RNA-based strategies to therapeutically target viral disease and have significant implications in advancing vaccine development.